Administration Core

ABSTRACT, Administration
The Indiana University Simon Comprehensive Cancer Center (IUSCCC) is a distinct organizational unit within
the IU School of Medicine. IUSCCC Administration works closely with the various units of the school including
Finance, Human Resources, Information Technology, Strategic Communication, Research Administration, and
Office of Clinical Research. Administration provides infrastructure support including finance, pre- and post-award
management of grants and contracts, financial management of Shared Resources, capital equipment
procurement, maintenance of common equipment in IUSCCC space, internal and external communications, and
support of the IUSCCC pilot project program.